Chemokines in healing myocardial infarction

ABSTRACT:
TGF- superfamily members play a central role in remodeling of the infarcted heart, modulating
phenotype and function of all cell types involved in myocardial inflammation, repair, and fibrosis. TGF-
s function by activating molecular cascades involving Receptor-activated Smads (R-Smads), or
through Smad-independent mechanisms. However, effective repair requires tight regulation of TGF-
actions, in order to prevent adverse consequences that lead to maladaptive cardiac remodeling.
Overactive, or prolonged TGF- signaling can promote cardiomyocyte, fibroblast and macrophage
activation, stimulating persistent fibrotic, hypertrophic and phagocytic responses. The endogenous
mechanisms responsible for negative regulation of TGF- responses in tissue repair, remodeling and
fibrosis remain unknown.
The current proposal explores the molecular mechanisms responsible for suppression and
termination of TGF- superfamily signaling in the infarcted and remodeling myocardium. Our
unpublished preliminary data suggest an important role for 2 distinct mechanisms in negative regulation
of TGF- superfamily signaling. First, cell-specific induction of the inhibitory Smads (I-Smads),
Smad7 and Smad6 may negatively regulate TGF- and BMP responses following myocardial
infarction. Second, TGF- signaling may be regulated at the receptor level through cell-specific
induction of the transmembrane pseudoreceptor BAMBI (BMP and activin membrane-bound
inhibitor), which lacks an intracellular kinase domain, and inhibits TGF- signaling, at least in part,
through interactions with I-Smads. The role of the cell-specific mechanisms for negative regulation
of TGF- will be explored in 4 specific aims:
Specific aim 1: to investigate the role of Smad7 in regulation of cardiomyocyte, fibroblast
and macrophage phenotype following infarction. Our preliminary studies show that Smad7 is
markedly upregulated in border zone cardiomyocytes, and in infarct myofibroblasts and macrophages,
and that Smad7 knockdown or overexpression modulate TGF--driven cellular responses. Accordingly,
we will use cardiomyocyte-, fibroblast/myofibroblast- and myeloid cell-specific Smad7 knockout mice,
recently generated by our laboratory to explore the cellular effects of Smad7 on the infarcted heart.
Specific aim 2: to dissect the molecular mechanisms responsible for the effects of
Smad7 in vivo and in vitro. Smad7 actions may involve suppression of Smad-dependent or non-
Smad pathways and may involve interactions with TRs, R-Smads or TGF--independent signals. Our
preliminary studies in cardiac fibroblasts suggest that Smad7 restrains Smad2/3 activation without
affecting phosphorylation of TRs. The molecular mechanisms for Smad7-dependent regulation of
cardiomyocyte, fibroblast and macrophage phenotype will be studied in vitro and in vivo, using both
loss and gain-of-function approaches.
Specific aim 3: to investigate the role of Smad6 in repair and remodeling of the infarcted
heart. Our preliminary studies show Smad6 induction in cardiomyocytes, fibroblasts, and macrophages
infiltrating the healing infarct, and demonstrate that fibroblast Smad6 exerts actions distinct from
Smad7-mediated effects. Conditional Smad6 knockout mice will be generated to dissect the cell-
specific actions of Smad6 in the infarcted and remodeling myocardium, and the mechanisms
responsible for Smad6-mediated effects will be explored in vivo and in vitro.
Specific aim 4: to study the role of BAMBI in regulation of TGF- responses in the
infarcted and remodeling heart. Our preliminary studies show that BAMBI is upregulated in infarct
myofibroblasts and macrophages. Accordingly, we will use fibroblast- and macrophage-specific BAMBI
knockouts and in vitro experiments, in order to study the role of BAMBI in modulating cell-specific TGF-
 actions in the infarcted heart. Moreover, we will explore interactions between BAMBI and the I-
Smads.
The proposed studies will provide the first systematic investigation of the mechanisms
responsible for negative regulation of TGF- in a model of tissue injury.

Public health relevance
NARRATIVE Members of the Transforming Growth Factor (TGF)- family are critically involved in regulation of inflammation and in repair following myocardial infarction; however, effective repair is dependent on timely inhibition of TGF- signaling to prevent persistent fibrogenic and hypertrophic responses The current proposal will investigate the mechanisms responsible for suppression and termination of TGF superfamily signaling cascades following infarction. In vivo experiments using cell-specific knockout mice and in vitro loss- and gain-of-function studies will be performed to dissect the molecular signals that inhibit TGF- responses in cardiomyocytes, fibroblasts and macrophages, thus protecting the infarcted heart from adverse remodeling.